XENOGENEIC CYTOTOXIC T CELL RESPONSES

Previous results from this laboratory have suggested tha Beta2 microglobulin, H-2 antigens, or other murine cellular proteins may influence the recognition of the human histocompatibility antigens HLA-A2 and -B7 by murine cytoxic T lymphocytes (CTL). This proposal will evaluate these factors in more detail. Cell lines expressing these antigens together with either murine or human Beta2 microglobulin will be produced by DNA-mediated-gene transfer in order to examine the influence of this peptide on CTL recognition. Previous results suggesting that HLA antigen recognition in theis sysytem can be H-2 restricted will be evaluated by production of stable cell lines expressing these antigens in the presence of different H-2 antigens. Finally, through the use of recombinant DNA technology, the third extracellular domain and cytoplasmic domains of the HLA antigens will be alterd or deleted. Recognition of these proteins by murine cytotoxic T lymphocyte precursors will be quantitated by limiting dilution analysis, and specificity on all targets assessed after short-term expansion of selected clones. These results will lead to a greater understanding of the role played by no-alloantigenic structural features of class I MHC antigens in T cell recognition processes.